Imaging microglial activation in aged marmosets

PROJECT SUMMARY/ABSTRACT
Aging is the greatest known risk factor for neurodegenerative disease development, such as Alzheimer’s disease
(AD). However, we lack an understanding of how aging predisposes the brain to these consequences.
Neuroinflammation is believed to play a prominent role in the early pathogenesis of AD. Microglia, the resident
macrophages of the central nervous system, are suspected to be key components of these changes as the
brain’s primary immune defense and principal players in neuroinflammation. The further development of non-
human primate models for AD and related dementias offers the opportunity to bridge the gap between knowledge
gained from rodent models and clinical testing in the elderly human population and to focus on key mechanistic
drivers such as microglia. While the common marmoset has proven to be a valuable resource and model for
translational aging studies, it is imperative we identify and evaluate early biomarkers of AD-like pathology in this
model. In this pilot project we will investigate whether neuroinflammation (microglial activation) and blood
analytes of inflammation are associated with age-related cognitive change in the common marmoset. This
application will build upon our previous research which has indicated that approximately 15-20% of aged animals
display marked cognitive decline, to test two hypotheses: (a) cognitive decline is associated with elevated
microglial activation in the hippocampus and prefrontal cortex, and (b) cognitive decline is associated with
elevated biomarkers associated with neuroinflammation and AD. In Aim 1, we will test the hypothesis that
cognitive decline is associated with elevated microglial activation in the prefrontal cortex and hippocampus. PET
imaging with 18F-DPA-714 (a second-generation radiotracer of the translocator protein 18kDA, TSPO) will be
used to image microglial activation. In Aim 2, we will test the hypothesis that cognitive decline is associated with
elevated peripheral biomarkers associated with inflammation and aging, including glial fibrillary acidic protein
(GFAP), soluble urokinase plasminogen activator receptor (suPAR), and inflammatory cytokines. The
development of these resources will further the marmoset as a model of early AD and associated dementias.

Public health relevance
PROJECT NARRATIVE Neuroinflammation is believed to play a prominent role in the pathogenesis of Alzheimer’s disease. In this pilot project we will investigate age-related cognitive decline in the common marmoset and evaluate the degree to which these changes are associated with microglial activation and biomarkers of systemic and central nervous system inflammation. The data will further the marmoset as a model of early AD and associated dementias.